Ultra-fast manufactured CAR-T therapy

Novel therapeutic approaches are urgently needed for patients with relapsed/refractory cancers.
Chimeric Antigen Receptor (CAR) T cell therapies have exhibited remarkable promise
particularly for patients with relapsed/refractory B cell malignancies. Though current CAR-T
therapies including FDA approved CD19 CAR-T products demonstrate efficacy in patients, there
are still major hurdles including high relapse rates and toxicities. In addition, there are major
issues with costs and accessibility of these products worldwide that are largely due to the
expensive and complex manufacturing processes. We have developed an ultra-fast (UF) CAR-
T manufacturing process that enables the production of CAR-T product in less than one day
using a simple and inexpensive workflow. Not only does the workflow improve the
manufacturing process, but the product also exhibits high promise to provide a product with
significantly improved efficacy and safety as compared to traditionally manufactured CAR-T
cells. We developed an initial CAR-T product, UF-Kure19, using this ultra-fast, less than 1 day
manufacturing workflow for which we just completed an initial phase 1 clinical trial. This trial
involved the treatment of 10 patients with relapsed/refractory non-hodgkin’s lymphoma and led
to an extremely promising safety and efficacy profile (80% complete remission rate).
Through this grant we aim to further develop this rapid CAR-T product by performing our next
phases of clinical development. Our objectives for this study are 1) To validate an automated,
closed system process for our manufacturing through a phase1b clinical trial and 2) To extend
our safety/efficacy clinical data in a defined subpopulation of patients with aggressive lymphoma
that often require rapid treatment delivery. It is hoped that this work will lead to a product for
lymphoma patients that demonstrates significantly improved efficacy and safety as compared to
the current FDA approved agents.

Public health relevance
This project is highly relevant to public health as its main objective is to lead to the development of a novel therapy for patients with relapsed/refractory cancer. It is hoped that this therapy will be more efficacious, cheaper and decrease the time to treatment for patients.